Maximizing Outcomes of Repeat Trichiasis Surgery Performed by Integrated Eye Care Workers

Project Summary
Trachoma is the leading infectious cause of blindness globally, and it disproportionally affects the
world’s most marginalized populations. Trachomatous trichiasis (TT) is a condition resulting from
years of repeated ocular chlamydia trachomatous infections that cause the eyelid to turn in and
the eyelashes to rub the eye, eventually leading to blindness. While surgery is available to correct
trichiasis, more than 20% of patients experience post-operative trichiasis (PTT) needing further
surgical management. Yet, current management procedures for post-operative trichiasis are
suboptimal. A recently completed clinical trial, BESRAT, compared an existing surgery procedure
(posterior lamellar tarsal rotation) against a newly developed procedure, Bevel-Rotate
Advancement Procedure (B-RAP). The trial used the best surgeons available. The trial suggested
that B-RAP performed better than the existing procedure, particularly for patients with severe PTT
or an eyelid contour abnormality at the time of repeat surgery. The next step is to determine
whether a larger group of TT surgeons can perform B-RAP well and to compare it against the
other standard TT surgery procedure, bilamellar tarsal rotation (BLTR).
The primary objective of this randomized clinical trial is to determine whether repeat trichiasis
surgery performed with B-RAP improves surgical success compared to BLTR among a group of
8-10 district TT surgeons in Tanzania. The study aims to enroll 1,000 individuals with PTT. The
primary outcome is repeat PTT within one year after surgery. Additionally, the study will assess
eyelid contour abnormalities and how they change over a two-year period as well as patient
reported outcomes.
If this project is successful in improving surgical outcomes, it could change the approach to
treating PTT globally. Individuals with trichiasis have a significantly reduced quality of life;
correcting their trichiasis long-term has the potential to improve their quality of life and their family
members’ quality of life considerably.

Public health relevance
Project Narrative This project will evaluate the effectiveness of a newly developed procedure, B-RAP, in improving post-operative trichiasis surgery outcomes and will assess whether a varied group of district-level trichiasis surgeons can perform B-RAP well. If successful, this project will increase access to sight-saving surgery for millions of people affected by this blinding condition. By preventing blindness through appropriate surgical correction, we ultimately may help to break the cycle of poverty for some of the world’s most underserved populations.